CODE-AKI: COnservative Dialysis to Enhance AKI Recovery

ABSTRACT/PROJECT SUMMARY
Dialysis-requiring acute kidney injury (AKI-D) is a devastating complication among hospitalized patients for
which there are no treatments other than supportive care. Recovery of sufficient renal function to stop dialysis
is an unequivocally important clinical and patient-oriented outcome. Shortening dialysis duration and increasing
the number of AKI-D patients who recover would have a major clinical, public health and cost-saving impact.
However, there is currently no evidence to guide the delivery of dialysis to facilitate recovery. We hypothesize
that in patients who have AKI-D and who are hemodynamically stable, a conservative dialysis strategy--in
which hemodialysis is not continued unless specific metabolic or clinical indications for RRT are present--will
improve the likelihood of renal recovery compared with the current standard clinical practice of thrice-weekly
intermittent dialysis. We have conducted a pilot clinical trial to demonstrate the feasibility of this approach. We
propose here a 2-center randomized controlled trial to test our conservative dialysis strategy in a larger AKI-D
population (N = 220). To shed insight into potential pathophysiological mechanisms, we will examine the
impact of the conservative dialysis strategy on not only clinical outcomes but also markers of renal tubular
injury and systemic inflammation. Our specific aims are:
Aim 1: In hospitalized patients with AKI-D, to test whether a conservative dialysis strategy (compared with a
standard thrice-weekly acute dialysis strategy):
a. Increases the proportion of patients with renal recovery at hospital discharge--the primary outcome for
this trial (defined as being alive and off dialysis at the time of discharge, with sustained independence
from dialysis for 14 days which may occur in or out of the hospital);
b. Reduces the number of dialysis sessions/week;
c. Increases the number of dialysis-free days to study day 28 (days alive and not dependent on dialysis,
similar to ventilator-free days).
Aim 2: To determine the impact of a conservative dialysis strategy (compared with a standard thrice-weekly
acute dialysis strategy) on renal tubular injury and systemic inflammation.
Renal tubular injury will be reflected by plasma neutrophil gelatinase-associated lipocalin and kidney injury
molecule-1 levels during the first week of the study intervention. Systemic inflammation will be reflected by
plasma interleukin [IL]-6, IL-8, IL-18 and soluble tumor necrosis factor receptor-1 levels. In aggregate, the
studies proposed here are the next step towards changing the paradigm of dialytic management in patients
with prevalent AKI-D and improving clinical outcomes in this vulnerable population.

Public health relevance
PROJECT NARRATIVE Acute kidney injury requiring dialysis is a devastating complication among hospitalized patients. There are currently no proven therapies to improve recovery of kidney function so that more patients can come off dialysis. We propose here a 2-center randomized controlled trial (N = 220) to test whether less frequent hemodialysis will improve the likelihood of renal recovery compared with the current standard clinical practice of thrice-weekly intermittent dialysis.